Targeting the ADAM10-sEphrin-B2 pathway in pulmonary fibrosis

Project Summary/Abstract
Pulmonary fibrosis is a fatal lung disease characterized by progressive destruction and scarring of the lungs.
Patients with the most common form, Idiopathic Pulmonary Fibrosis (IPF), suffer from irreversible and
ultimately fatal interstitial lung disease characterized by progressive decline in lung function, ultimately
impeding the ability to breathe. Activation of scar-forming cells named myofibroblasts is the driving force
behind progressive lung scarring, excessive extracellular matrix (ECM) deposition and tissue remodeling
associated with pulmonary fibrosis. Accordingly, the identification of the molecular mediators directing
myofibroblast activation, will not only further enhance our understanding of the pathogenesis of lung fibrosis,
but also provide rational therapeutic targets for novel anti-fibrotic therapies. We have recently identified the
ADAM10-sEphrin-B2 pathway as a major driver of myofibroblast activation in patients with IPF and in mouse
models of lung fibrosis. Our recent studies have demonstrated that following lung injury the ectodomain of full-
length ephrin-B2 in quiescent lung fibroblasts is proteolytically cleaved by the disintegrin and metalloproteinase
ADAM10, resulting in the generation of the biologically active molecule soluble Ephrin-B2 (sEphrin-B2). Once
shed, sEphrin-B2 generates pro-fibrotic signaling to quiescent fibroblasts by activating EphB4 receptor
signaling in an autocrine/paracrine manner. Our studies demonstrate that sEphrin-B2/EphB4 receptor signaling
promotes differentiation of quiescent fibroblasts into activated myofibroblasts and is sufficient to drive tissue
fibrosis in mice in vivo. Further, mice genetically lacking ephrin-B2 specifically in lung fibroblasts exhibit
significant protection from bleomycin-induced lung fibrosis. Consequently, we hypothesize that strategies to
interrupt the elaboration of sEphrin-B2, by targeting ADAM10, or blocking sEphrin-B2 directly, have the
potential to serve as novel therapeutic strategies for lung fibrosis. The studies proposed in this application are
designed to define the biological mechanisms by which the ADAM10-sEphrin-B2 pathway drives lung fibrosis
and to develop novel therapeutic strategies to inhibit this pathway in patients with IPF. Specifically, we propose
four specific aims: (1) To determine the cellular mechanisms by which ADAM10 generates sEphrin-B2 in vivo
and contributes to the development of lung fibrosis, (2) To investigate the mechanisms by which sEphrin-B2
induces myofibroblast activation in vitro, (3) To determine the therapeutic efficacy of anti-sEphrin-B2
neutralizing antibodies in preclinical and human IPF models, and (4) To evaluate plasma sEphrin-B2 levels as
a novel prognostic biomarker in IPF. The experiments proposed in this application will delineate novel
mechanisms whereby the ADAM10-sEphrin-B2 pathway promotes lung fibrosis. We will also determine
whether therapeutic blockade of this pathway has the potential to be an effective new therapeutic strategy for
IPF, an incurable and deadly disease.

Public health relevance
Project Narrative Idiopathic Pulmonary Fibrosis (IPF) is a common lung disease that invariably leads to a progressive decline in lung function, resulting in significant morbidity and mortality. We have recently identified the ADAM10-sEphrin- B2 pathway as a major driver of myofibroblast activation, effector cells that cause scarring of the lungs. The experiments proposed in this application are designed to delineate novel mechanisms whereby the ADAM10- sEphrin-B2 pathway promotes lung fibrosis, and to determine whether therapeutic blockade of this pathway has the potential to be an effective new therapeutic strategy for IPF, an incurable and deadly disease.